Inhibitory Regulation of Neural Circuit Plasticity in Visual Cortex

Project Summary
The proposed work addresses a problem highlighted by the NEI Audacious Goals Initiative as “essential to
resolve”: identifying ways to regenerate damaged neurons and promote their reconnection to the correct targets
in the central nervous system. In mice, a crushed optic nerve can be regenerated by concurrent manipulation of
growth-control pathways and neural activity. Yet these regenerating optic nerves may not form appropriate
connections because they grow into an atrophied thalamus whose inputs to cortex are weakened. Thus,
functional regeneration requires strengthening of thalamocortical inputs representing the damaged eye to re-
establish binocular mapping of visual space onto cortical circuits. Similar challenges are faced in early postnatal
development, when a weak incoming input from the ipsilateral eye must match the mapping laid down in a cortex
already dominated by the contralateral eye. This proposal examines the circuit mechanisms in primary visual
cortex necessary for successful regeneration and integration of weak inputs in primary visual cortex, using in-
vivo two-photon microscopy of calcium activity in alert mice and whole-cell slice electrophysiology, and then tests
the effectiveness of inducing similar conditions in adulthood. The overall hypothesis is that compartmentalized
dendritic activity promotes large-scale integration of new inputs into primary visual cortex. Preliminary data
suggest that direct cholinergic input to one class of inhibitory neurons, the regular-spiking, somatostatin-
expressing interneurons that inhibit dendrites, is lost as the critical period closes, leading these neurons to shift
from compartmentalized dendritic activity to more synchronous activity. Chemogenetic control of somatostatin
interneurons will be used to promote dendritic compartmentalization in adult cortex and to test whether this
enhances regeneration. These experiments are expected to reveal new mechanisms that explain how the
closure of a critical period in visual development reduces the capacity for establishment and strengthening of
synaptic connections in cortex. In the long term, this knowledge is likely to promote incorporation of weak inputs
onto their appropriate targets during regeneration after injury or disease in adulthood, which would achieve a
key goal of the NEI and improve treatment options for vision loss.

Public health relevance
Project Narrative To ameliorate the devastating problem of vision loss due to neural injury or degeneration, researchers must learn how to overcome the limited capacity for large-scale plasticity in the adult central nervous system. This proposal will first determine the role of dendritic compartmentalization in solving a similar problem in the juvenile brain, where weak inputs from one eye must grow into a cortex that is already dominated by inputs from the other eye. Then it will evaluate the effectiveness of artificially inducing dendritic compartmentalization for promoting the incorporation of weak inputs in adult brain, suggesting new approaches to treatment of common vision disorders such as cataracts, amblyopia, or glaucoma.